Identifying transcriptional interplay between skin and oral ectoderm during mandibular patterning

PROJECT SUMMARY: Development of the mouth is complex, requiring the proper segmentation of epithelial
domains along the dorsoventral axis into oral, dental, and skin lineages. Congenital defects impacting
structures derived from these lineages are common and can be severely debilitating for those afflicted, thus
necessitating a precise understanding of their underlying genetic control. Knockout (KO) mouse models have
begun to identify genetic programs responsible for driving individual epithelial lineages. However, despite these
efforts, if and how these programs (oral, dental, skin) intersect and their functional influence on one another
remains poorly understood. We found that in the mandibular ectoderm SHH, Sox2, Pitx1 and Pitx2 are strongly
expressed on the dorsal, oral/dental-fated side, while WNT, Tfap2a and Tfap2b are strongly expressed on the
ventral, skin-fated side. While expression domains initially overlapped at E9.5, they formed complementary
expression domains at E11.5, coincident with the specification of oral/dental or skin fates. Highlighting the
functional significance of these partitioned networks, early ectodermal double KO of Tfap2a/Tfap2b (Tfap2-
LOF) led to a ventral expansion of the oral/dental domain, including associated transcription factors, signaling
pathways, and structures, such as an ectopic incisor. Conversely, KO of Pitx2, associated with arrest of the
dental lineage, led to a dorsal expansion of the skin domain, including associated transcription factors and
signaling pathways. Our overall objective with this proposal is to determine how interactions between different
groups of transcription factors—namely, SOX2/PITX1/PITX2 and TFAP2A/TFAP2B—drive the specification of
oral/dental or skin fates, respectively, within the mandibular ectoderm. In Aim 1, we will determine how these
domain specific transcription factors, including SOX2, PITX1, and PITX2 in the dorsal oral/dental epithelium
and TFAP2A and TFAP2B in the ventral, aboral, skin epithelium counteract one another, to both strengthen
and refine these domains. In Aim 2, we will identify how TFAP2 programs a ventral/skin identity, including
regulation of this program at a chromatin level. Finally, in Aim 3, we will identify the cellular and molecular
underpinnings associated with the expanded dorsal domains, including communication between epithelium
and underlying mesenchyme, and the involvement of SHH and WNT in defining odontogenic competence of
the underlying mesenchyme, in Tfap2-LOF embryos. Collectively, using a strong set of in vivo animal models,
explant, and genome wide assays, these studies will fill a critical knowledge-gap in our current understanding
of epithelial patterning along the dorsal-ventral axis of the mandible. The Principal Investigators of this MPI
study have complementary expertise in relevant areas for this proposal. They will collaborate with Dr. Kenny,
an expert in gene regulatory networks and genome wide assays. Collectively, the experimental design and
approach, the PIs, and the environment outlined provide the catalyst to improve oral and craniofacial health.

Public health relevance
PROJECT NARRATIVE: Despite the prevalence of orofacial and dental defects, our current understanding of early patterning of these structures is limited. The overall objective of this proposal is to identify the genetic control of these early patterning events. The long-term goal is to apply the mechanisms uncovered to understand their associated congenital disorders and for regenerative therapeutic approaches.